Viral mechanism for engaging lytic cycle promoting host transcription factors

Abstract
Kaposi's sarcoma-associated herpesvirus (KSHV) is a human tumor virus that is the etiological agent of several
AIDS-related malignancies such as B cell lymphomas and Kaposi's sarcoma. KSHV establishes viral latency in
most cell types following primary infection but can undergo lytic reactivation. The key viral factor, which drives
the lytic cycle of KSHV, is the replication and transcription activator called RTA. We and others have identified
the genome-wide targets of RTA and we have also demonstrated the need for the rapid induction of specific host
genes concomitantly with the viral genes for efficient lytic reactivation. Uncovering the protein interaction
domains of host factors that viral proteins bind to and are crucial for lytic reactivation is important, because they
can serve as potential targets for antiviral therapies to abrogate viral transmissions. Our study focuses on one
such domain of host factors called the Forkhead-associated (FHA) domain. This is a unique protein-protein
interaction domain, which recognizes and binds to specific conserved short linear motifs in proteins. FHA proteins
have diverse functions in the regulation of transcription, DNA repair, replication stress response and cell cycle
checkpoints. Viral proteins often mimic host protein interaction motifs thereby hijacking host factors and alter
cellular functions. Through our unbiased in silico protein sequence screening of KSHV proteins, we identified
several viral proteins possessing putative FHA interaction motifs. We hypothesize that these KSHV viral factors
can bind to FHA proteins to alter their cellular functions to promote lytic cycle. To test this concept, here we aim
to dissect the mechanism of one of these novel viral-FHA protein pairs and determine its role in the regulation of
KSHV lytic cycle. We will also evaluate how this finding can be used for an antiviral therapy against KSHV.

Public health relevance
Narrative Herpesviruses encode proteins that can hijack host pathways to promote viral replication, by mimicking key cellular factors to usurp their partners. Here we set out to characterize such novel virus-host interactions that can support viral replication and transmission. We will systematically identify the biological functions of these interactions to develop new targets for potential future antiviral therapies.